INFORMATION TECHNOLOGY AND APPLICATIONS CENTER (ITAC) PROJECT MANAGEMENT SUPPORT

Task Area #1: Project Management Support – Support ITAC in the release and award of information technology, information security and data science-related projects in close collaboration with business owners, and ITAC staff.